Structural biology core

CORE 4: SRUCTURAL BIOLOGY
SUMMARY
Structural biology plays a key role in elucidating molecular mechanisms of biological processes and in
therapeutic development. De novo structure elucidation can delineate novel interaction interfaces guiding
fundamentally new drug screening campaigns. Molecular structures can be used as targets for computational
docking to obtain novel chemotypes that can then be optimized to become potent inhibitors. Visualizing protein
structures bound to inhibitor hits or leads at a high resolution is invaluable for the chemists rationally optimizing
compounds based on the protein binding pocket. The central role of structural biology in developing therapeutics
is underlined by the fact that it is involved in three stages of the QCRG Drug Discovery Platform and every
Project. The goal of the Structural Biology Core is to provide cutting-edge X-ray crystallography and cryo-
electron microscopy (Cryo-EM) services to the Projects. Core Investigators have a track record of technological
development in both X-ray and Cryo-EM fields and a history of very effectively working together. A testament to
this is that at the start of the COVID-19 pandemic, we formed the QCRG Structural Biology Consortium (QCRG
SBC), which in the span of a year yielded five structure-based publications on SARS-CoV-2. This experience
allowed for fine tuning the practical aspects of working together like sharing common facilities, having regular
project focused meetings and online spaces for continued project discussions, databases for reagents and
project progress, etc. Therefore, the Structural Biology Core will present a seamless one stop solution for the
structural biology needs of this proposal. Specifically, in Aim 1, we will provide support on X-ray crystallography
based structural studies for proteins that express in suitable quantities. Crystallography will be especially
important for visualizing hit and lead compounds bound to their targets at the highest possible resolutions to
drive structure-based drug design. Our robotized high-throughput screening facilities allow for setting up and
inspecting tens of thousands of nanoliter sized crystal drops (including membrane proteins), enabling rapid
condition screening. We share beamline 8.3.1 at Lawrence Berkeley National Laboratory (LBNL) with regular
time slots available for data collection, allowing for regular and easy access to a high flux X-ray source. In Aim
2, we will leverage our state-of-the-art facilities to enable Cryo-EM studies of viral proteins and complexes. We
have fully staffed facilities with five Field Emission Gun (FEG) microscopes equipped with the latest direct
detector cameras and access to high performance computing clusters and GPU workstations for processing. For
Cryo-EM studies, we will leverage our recent advances in grid technology, denoising and incorporation of artificial
intelligence (AI) predicted protein structures, to resolve previously unseen viral protein interactions. In addition,
we have set up the UCSF Center for Cellular Structural Analysis enabling high-resolution in situ cryo-EM
tomographic studies of virus-like particles. Overall, the Structural Biology Core will provide atomic resolution
insights to the proposal at all scales and resolutions, driving therapeutic development at all stages of the Project.